Adaptive Immune Responses to Congenital and Postnatal Cytomegalovirus Infection

ABSTRACT
Congenital cytomegalovirus (cCMV) infection is the most common congenital viral infection in the U.S,
affecting 1 in 200 liveborn infants annually, and can cause permanent neurodevelopmental and hearing
impairment. In contrast, postnatal CMV infection in full-term infants causes no clinical illness or neurologic
sequelae. The immunologic differences underlying the clinical manifestations induced by cCMV but not postnatal
infection are undefined. Our group recently found that cCMV infected infants expressed a spectrum of CD8+ T
cell responses, ranging from naïve-like T cells (TN) resembling those of CMV uninfected newborns, to highly
differentiated cells with features of T cell exhaustion (TEX). By comparison, the CD8+ T cells of postnatally infected
infants were differentiated and lacked TEX characteristics. Importantly, cCMV-induced developmental delay was
associated with the TN-like phenotype, whereas progressive SNHL was associated with persistent TEX-like cells,
underscoring the clinical relevance of understanding these T cell responses to cCM infection.
This project will test the central hypothesis that cCMV infection impairs the infant’s T cell response to CMV,
impeding effective viral control and increasing risk for neurologic injury. We will compare CD4+ and CD8+ T cell
responses to CMV between a large enrolled cohort of cCMV infected infants and a group with early postnatal
CMV infection acquired through breastfeeding. Aim 1 will identify pathways inhibiting Th1 cell responses after
cCMV infection by assessing several possible causes for the lack of neonatal Th1 responses during cCMV
infection: (1) Th1 cell differentiation occurs, but cytokine-secreting function is limited by inhibitory signals; (2)
Th2/Treg cells develop preferentially, inhibiting Th1 cell differentiation; (3) TLR signaling by dendritic cells is
inhibited by cCMV infection, reducing cytokine and proliferative signals to CD4+ cells. Comparisons between
cCMV and postnatally infected infants will identify key differences in the CD4+ T cell responses and their
upstream regulators. Aim 2 will identify differences in CD8+ T cell responses induced by congenital and postnatal
infection and the T cell characteristics associated with cCMV-induced neurodevelopmental impairment. In this
Aim, the surface receptor and transcriptional profiles of antigen-specific CD8+ T cells will be compared between
cCMV and postnatally infected infants to discern distinctive features generated during cCMV infection in the
absence of CD4+ T cell help. Anti-PD-1 antibodies will be used in-vitro to test if function can be restored to CD8+
TEX cells induced by cCMV infection. The CD4+ and CD8+ T cell parameters associated with cCMV-induced
neurodevelopmental impairment will be identified. Together, these studies will advance our fundamental
understanding of human T cell responses to a congenital viral infection and their potential impact upon neurologic
outcomes. This knowledge may inform development of new therapeutic approaches to reinvigorate T cells and
improve neurodevelopmental outcomes among cCMV infected infants.

Public health relevance
NARRATIVE Congenital cytomegalovirus (cCMV) infection can cause severe symptoms and permanent neurodevelopmental impairments and hearing loss, whereas postnatal breastfeeding-acquired CMV infection in full-term infants causes no clinical illness or neurologic sequelae. Our group recently found that cCMV-induced developmental delay was associated with a lack of in-utero T cell differentiation, whereas progressive sensorineural hearing loss was associated with persistent features of T cell exhaustion that were not observed after postnatal infection. To understand the T cell responses to cCMV infection and their potential impact upon neurologic outcomes, a large cohort of cCMV infected children will be compared to postnatally infected children with respect to antiviral T cell characteristics and their downstream impact upon viral replication and neurodevelopmental outcomes.